Enhancement of RGC survival and Optic Nerve Regeneration by Cytokine Polarized Myeloid Cells

Abstract
A significant percent of individuals with optic nerve (ON) injuries, secondary to trauma or glaucoma, suffer
permanent visual loss. The adult mammalian visual system has a limited capacity for self-repair, making it
vulnerable to damage and degenerative processes. Mature retinal ganglion cells (RGCs, the projection neurons
of the eye) do not replicate, and severed ON axons have a limited capacity to regrow, increasing the likelihood of
poor visual outcomes. Various strategies, such as genetic reprogramming of RGC, blockade of endogenous axon
growth inhibitors, and biomaterial transplantation, have been attempted in animal studies to promote axon
regeneration, but none have been curative. Successful outcomes in the clinical setting will likely require
personalized, multimodal approaches using synergistic therapeutic agents. A promising strategy for restoring
the integrity of injured tissue is to deploy natural immune driven healing pathways. Immune-drive healing has
been convincingly demonstrated in animal models of cutaneous wounds and myocardial ischemia. There is an
increasing recognition of the potential for immune responses to drive repair in the eye as well. However, the
specific immune cell populations involved, and their mechanisms of action, are poorly understood. In
preliminary experiments, we showed that immature bone marrow neutrophils (BMN), harvested from naïve
mice, express markers of alternative activation and acquire neuroprotective pro-regenerative properties
following short term polarization with interleukin (IL)-4 and granulocyte-colony stimulating factor (G-CSF).
These novel cells promote RGC survival and drive RGC axon regrowth, both in vitro and in animal models of
optic neuropathy, at least partially through the secretion of soluble factors. Similarly, IL-4/G-CSF polarized
human BM myeloid cells, as well as their conditioned media, promoted neurite outgrowth of human iPSC derived
RGCs. A major goal of the current proposal is to elucidate the factors secreted by the IL-4/G-CSF polarized
murine BMN that contribute to their reparative effects. Additionally, we will investigate how these BMN
modulate glial cells in the eye to promote a neuroprotective phenotype. Lastly, we will characterize pro-
regenerative human BM myeloid cells in depth, explore their mechanisms of action, and develop protocols to
expand them in vitro, in a manner that preserves their reparative properties. We are hopeful that, collectively,
the results of these experiments will inform the development of the first autologous myeloid cell therapies that
promote visual recovery in individuals with optic neuropathy. Furthermore, this line of research could lead to
the development of therapeutic cocktails of pharmaceutical agents, nanoparticle-based therapies, and/ or gene
therapies, that mimic the mechanism of action of the IL-4/G-CSF polarized myeloid cells.

Public health relevance
Project Narrative People living with glaucoma or optic nerve trauma may experience vision loss because the nerve cells in the retina that send visual signals to the brain can die, and their fibers don't regenerate. Through initial experiments, we discovered a way to generate a new type of white blood cell from both mouse and human bone marrow stem cells that help retinal nerve cells survive, and even regrow their fibers, both in lab dishes and in animals with optic nerve injury. This proposal aims to further explore the mechanisms of these cells, bolster their healing potential, and ultimately devise therapies for vision restoration in affected individuals.